Husbandry and Management Core

PROJECT SUMMARY - Core A: Husbandry and Management Core
SPF4 Indian-origin rhesus macaques are the premier animal model for HIV/AIDS research, including studies of
HIV pathogenesis, AIDS-related opportunistic infections, and the development of treatments and vaccines for
HIV and AIDS. Demand for this resource continues to grow and is projected to increase over the grant cycle. A
predictable supply of disease-free, genetically characterized nonhuman primates is critical to succeed in the
fight against HIV/AIDs. The U42 SPF 4 Rhesus macaque breeding colony for AIDS research produces MHC
class-1 typed rhesus macaques (Macaca mulatta) who are maintained negative for simian immunodeficiency
virus (SIV), simian T-lymphotropic virus (STLV-1), simian retrovirus (type D retrovirus or SRV), and macacine
herpesvirus-1 (BV). The overall aim of the Husbandry and Management Core is to sustainably manage the
ONPRC Specific Pathogen Free (SPF) rhesus macaque breeding colony for AIDS research at a targeted
population of 200 adult breeder females capable of producing at least 130 animals annually for research use.
To achieve this, we will provide innovative team-based management practices including new social monitoring
strategies, a weight management program for at-risk infants, improved assays for disease screening and
preventive health needs, and continued genetic selection strategies that maximize diversity.